The role and regulation of p53 in obesity-induced liver cancer

Project Summary/Abstract
Obesity is a prevalent global health problem, and it increases the overall risks of many types of chronic
diseases and cancers. Nonalcoholic steatohepatitis (NASH) is a major liver complication of obesity, and
importantly, the fastest growing etiology of hepatocellular carcinoma (HCC) with alarming future
projections. However, how obesity and NASH contribute to the development of NASH-driven HCC is ill-
defined, hindering the comprehensive understanding of the disease and the development of effective
therapeutics. While p53 is a well-defined tumor suppressor, its involvement in NASH and associated
HCC is poorly understood. In a dietary mouse model of NASH, p53 protein is initially stabilized in early
stages of NASH but lost prior to tumorigenesis, while p53 loss is sufficient to promote HCC in mice with
NASH. In human patients, NASH-driven HCCs from obese subjects display a lower frequency of
genomic TP53 inactivation compared to lean ones, raising the idea that p53 functions are impaired by
NASH that facilitates the progression to HCC without necessitating genomic p53 loss.
The preliminary data suggest that obesity and NASH profoundly shape the cancer genotypes. The
objective of this proposal is to understand how obesity and NASH influence the activity of p53, as well as
the selective pressure against p53 to drive HCC. The central hypothesis is that p53 inhibition by NASH-
associated cholesterol accumulation is an early and critical event linking NASH to tumorigenesis. The
following specific aims are proposed to test the hypothesis: 1) to dissect the functions of p53 and
senescence, and to identify p53 downstream effectors in suppressing NASH-driven HCC; 2) to determine
the effects of cholesterol and cholesterol-lowering drug statin on p53 activity during NASH-to-HCC
transition to elucidate a mechanism by which p53 is inhibited. These studies will apply a dietary mouse
model of NASH and HCC along with the state-of-art tools of molecular biology and genetics.
Findings from the studies will discover a potentially critical mechanism linking obesity and NASH to liver
malignancy, as well as the novel biology of p53 and NASH. The results will also reveal new therapeutic
possibilities to combat NASH-driven HCC, such as repurposing cholesterol-lowering drug and/or
exploring new tractable targets within the p53 network.

Public health relevance
Project Narrative Obesity is a global health concern that increases the risks of many types of human cancers including liver cancer, but how obesity leads to liver cancer is poorly understood. The proposed study focuses on the pathogenic mechanisms of obesity-induced liver cancer, by investigating the functions and regulation of the critical tumor suppressor p53 during disease progression in mouse models. The findings from the proposal will help the scientific community understand conceptually how obesity contributes to the development of liver cancer, and yield strategies of developing potential therapeutics to treat obesity-induced liver cancer.